Real-Time Mobile Assessment of Daily Functioning Among Older HIV-Infected Adults

PROJECT SUMMARY/ABSTRACT The proposed K23 application will strongly support Dr. Raeanne Moore's long-term career goal of becoming an independent clinical scientist investigating and promoting optimal functioning among older HIV+ adults, with applied expertise in using innovative mobile health technologies. The proposal has considerable

Public health relevance
PROJECT NARRATIVE Daily functioning difficulties are common among older persons living with HIV, and disability costs associated with these impairments place a significant burden on society. Available assessment methods do not capture the combination of risk and protective factors impacting daily functioning at the intersection of HIV and aging, and the proposed study will use Ecological Momentary Assessment (EMA) as a low cost, efficient, objective measure of functioning among older persons with HIV. Understanding the primary factors leading to functional impairments at an individual level will inform the development of new interventions aimed at reducing disability and improving overall quality of life among older persons living with HIV.